OPEN LABEL PROTOCOL TO ASSESS STEADY STATE PHARMACOKINETICS OF FAMPRIDINE

To assess the steady state pharmacokinetics of sustained release fampridine tablet administration in patients with multiple sclerosis. We will be starting Phase II, placebo-controlled safety of 4-AP. Time frame unknown.